CRISPR-Cas13-based rapid HIV-1 test

HIV is one of the most deadly infectious diseases in the world. HIV transmission is largely driven by acutely
infected individuals who are unaware of their status or those receiving antiretroviral therapy but not virally
suppressed. Currently available rapid HIV tests, including fourth-generation HIV antigen/antibody combo tests,
lack the sensitivity needed for detecting HIV during early stages of acute infection and viral rebound. Nucleic
acid amplification tests (NAATs) that detect HIV-1 RNA, which can be detected in as early as 5 to 10 days after
viral transmission, offer superior sensitivity and are currently the gold standard for detecting HIV during acute
infection and viral rebound. However, NAATs are laborious, time-consuming and rely on expensive
instrumentation and refrigerated components, hindering their use for self-testing.
Therefore, the objective of this project is to develop and validate a shelf-stable, instrument-free CRISPR-
Cas13-based rapid test for highly sensitive HIV-1 detection in blood or saliva. This high-risk, high-reward
approach is fundamentally different from existing NAATs that involve multiple steps of sample preparation (RNA
extraction and amplification) or require laboratory instrumentation or refrigerated components. Our rapid HIV-1
test will employ an engineered Cas13a enzyme with enhanced collateral activity and stability, and lyophilized
assay components for enhanced shelf life while offering a simplified workflow that can be performed in home
settings (similar to COVID-19 antigen rapid self-tests). A phone app will automatically analyze the readout from
the lateral flow device and present the test results in a clear, simple-to-interpret manner. The rationale for this
research is supported by the applicants' preliminary data demonstrating highly sensitive detection of viral RNA
using a rapid, lateral flow CRISPR-Cas13-based assay and the development of an RRM2-L Cas13a enzyme
with enhanced collateral activity and stability. In the R61 phase, we will pursue the following specific aims:
1) Characterize HIV-1 RNA levels in saliva and blood from a diverse population of people with HIV;
2) Investigate strategies for user-friendly device operation;
3) Develop a shelf-stable, instrument-free CRISPR-Cas13 rapid test for highly sensitive HIV-1 detection.
If the R61 phase milestones are achieved, we will further develop and characterize this platform and validate its
functionality using clinical HIV specimens during the R33 phase by pursuing the following specific aims:
4) Further develop and characterize the lateral flow CRISPR-Cas13-based rapid HIV-1 test;
5) Validate the functionality of the CRISPR-Cas13-based rapid HIV-1 test using clinical specimens.
This approach is innovative because it combines the speed, simplicity and affordability of lateral flow-based
diagnostic tests with the high sensitivity of CRISPR-Cas-based nucleic acid detection, and it is significant
because it will improve the effectiveness of HIV self-testing for early diagnosis and patient monitoring during ART
therapy, thus minimizing unintentional HIV transmission and reducing HIV-associated morbidity and mortality.

Public health relevance
The proposed research is relevant to public health because it will result in the development of a user friendly, rapid HIV self-test for detecting early stages of acute infection and viral rebound in individuals receiving antiretroviral therapy. Thus, the proposed research is relevant to NIAID's mission by advancing HIV research and improving human health through the development of new diagnostics tools to improve the diagnosis and clinical management of HIV-infected individuals.